CHILD MENTAL HEALTH SERVICES & SERVICE SYSTEM RESEARCH

DESCRIPTION (provided by applicant): This is a request for funds for 10 pre-doctoral and 4 postdoctoral fellows for a training program in child mental health services research. The training program will provide a public health perspective on the study of the need for and use of services for children and adolescents with mental disorders with an emphasis on research that changes clinical practice and that improves the mental health of children and adolescents. The program will be operated jointly by the Departments of Mental Hygiene and Health Policy and Management of the Johns Hopkins Bloomberg School of Public Health and expanded to include pre-doctoral fellows from the Department of Health Policy and Management. The training program seeks to continue to address the shortage of researchers capable of conducting studies of mental health services and systems of services for children and adolescents with serious emotional disturbances. It is expected that pre-doctoral fellows will require 3-4 years of funding and postdoctoral fellows 2-3 years of funding. A rich collaboration of faculty from different departments, programs, and centers will be involved, including: the Center for Research on Service for Severe Mental Illness, the Center for Mental Health Services Research at the University of Maryland School of Medicine, the Johns Hopkins Center for the Prevention of Youth Violence, the Johns Hopkins Prevention Research Center, and the Division of Child and Adolescent Psychiatry at Johns Hopkins School of Medicine. The Director of the program is Dr. Philip Leaf, Professor in the Department of Mental Hygiene, and the Co-Director is Dr. Anne Riley, Associate Professor in the Department of Health Policy and Management.